Emergency Trauma Care: Analysis of disparities in the pre-hospital emergency trauma care system

Trauma is the leading cause of death for children and adults 46 years and younger, killing more Americans than AIDS and stroke combined. African Americans (OR 1.2, P<0.001), people living in high poverty neighborhoods (OR 1.01, P<0.001), and those enrolled in public health insurance programs (OR 1.53, P<0.001) have increased mortality after trauma when compared to their injured counterparts. Quantifying disparities in access to Emergency Medical Services (EMS) and designated/verified trauma centers (TCs), as well as the extent to which timely access to care improves health outcomes are critical first steps to address this alarming discrepancy. Expeditious availability to EMS has yet to be evaluated and timely access to TCs is understudied. In fact, no one has explored the importance of expeditious availability to emergency health care services such as EMS and timely access to emergent trauma care as key social drivers of health (SDoH). Models to evaluate the role of SDoH as major predictors of these disparities remain untested. Rapid transport to a TC is associated with a 25% reduction in mortality; however, nearly 45 million Americans lack timely access to a verified TC. When compared to majority populations, recent data show some populations have significantly less access to TC and worse outcomes following trauma. Understanding the factors that determine trauma-related socio-spatial disparities can inform interventions at both the policy and system levels to mitigate the disproportionately large numbers of deaths experienced by some populations. Thus, there is a compelling need for research in these areas to facilitate targeted interventions to eliminate socio-spatial disparities within the pre-hospital phase of the emergency trauma care system to improve patient outcomes. To evaluate socio-spatial disparities in availability and access to both EMS and to TCs among critically injured trauma patients, we will evaluate the pre-hospital phase of the emergency trauma care system (availability to EMS, EMS response time, EMS scene time, EMS transportation time, EMS decision to transport to TCs vs. non-TCs, and EMS total prehospital time) and use large national databases to develop spatiotemporal models to assess drivers of disparities in traumatic injuries. Our interdisciplinary team will use data science methods and novel analytics to address this critical public health need by identifying health disparities at the level of the pre-hospital emergency trauma care system.

Public health relevance
Rapid transport to a designated/verified trauma center (TC) is associated with a 25% reduction in mortality among injured patients; however, timely access to Emergency Medical Services (EMS) and to emergency health care services such as trauma care is understudied. We aim to identify socio-spatial disparities in the expeditious availability to EMS and access to TCs among critically injured trauma patients, factors driving those disparities, and the association of those disparities with patient outcomes. This project will enhance the knowledge necessary to design interventions and policies at the system level to improve outcomes by reducing and eliminating disparities in trauma morbidity and mortality.